Bone Morphogenic Protein Receptor 1a signaling controls stability of Treg cell phenotype

Abstract
Despite extensive studies, environmental cues and signaling circuits regulating onset of autoimmune
diseases are not completely understood. Here we report that a receptor of the TGF-β cytokine family, Bone
Morphogenetic Protein Receptor 1α (BMPR1α, Alk-3) has important immunoregulatory functions. BMPR1α is
upregulated by activated effector and Foxp3+ regulatory CD4+ T cells (TR cells) and modulates functions of
both of these cell types. BMPR1α regulates inflammation by inhibiting generation of Th17 cells and sustaining
TR cells. Abrogation of BMPR1α signaling in TR cells resulted in a gradual loss of Foxp3 expression and
upregulation of transcription factors and cytokines specific for Th effector lineage including Rorgt, Batf, Hif1a,
IL-17 and IFN-g. This data suggests that BMPR1α controls phenotypic stability of TR cells and regulates
Th17/TR balance, critical for maintenance of peripheral tolerance and protection from autoimmune diseases.
Cells which downregulate Foxp3 convert into effector Th cells (exTR cells) which produce proinflammatory
cytokines and contribute to disease pathology in a number of autoimmune diseases. A recent RNA-seq
transcriptome analyses of BMPR1α-deficient TR cells in situ showed upregulation of a number of epigenetic
modifiers and transcription factors specific for effector Th cells including Med14, Supt16H, Setbp1, Tbx21
(Tbet) and Maf.
These new data demonstrate that BMPR1α-deficient TR cells in unmanipulated mice are predisposed to
follow epigenetic and transcription programme to dedifferentiate to exTR cells when subject to antigenic
stimulation and inflammation.
To gain mechanistic insight on the immunoregulatory role of BMPR1α we will combine ATAC-seq and RNA-
seq analyses of epigenetic profile and transcriptomes to identify molecules involved in TR/exTR transition.
We will test if TR/exTR transition can be regulated by pharmacological modulation of BMPR1α dependent
signaling pathways. We have found that at the molecular level BMPR1a deficiency in TR cells led to
upregulation of Kdm6b (Jmjd3) demethylase, an antagonist of polycomb repressive complex 2 (PRC2). We will
examine if phenotype of BMPR1a deficient TR cells could be sustained by Kdm6b inhibitor. We will also
generate mouse models to test additional compounds for their ability to impact BMPR1a signaling and
modulate TR cell stability. In summary, proposed research will contribute to our understanding of
immunoregulation and has the potential to outline new therapeutic strategies for inflammatory and autoimmune
diseases.

Public health relevance
Project narrative The proposed research will examine how Bone Morphogenic Protein Receptor1α regulates balance of TR and exTR cell subsets to prevent autoimmune diseases. We will investigate how BMP\BMPR1α signaling operates in vivo to regulate tissue tolerance and inflammation.